Targeted Localization and Optimized Surgical Resection for Lung Cancer

ABSTRACT
In the US, nearly 230,000 new lung cancer cases are diagnosed annually, many at an early stage when
they are smaller than 1 cm in diameter. For small tumors, sublobar resection such as segmentectomy is
performed to resect the entire tumor with sufficient margins (distance between the edge of the tumor and the cut
line). Although segmentectomy preserves lung function better than lobectomy (removal of entire lung lobe), it is
associated with a higher locoregional recurrence rate (10.5% vs. 5.4%). This could be attributed to the critical
challenges of 1) reliably localizing small, non-palpable nodules, and 2) resecting them with sufficient margins to
ensure removal of all malignant tissue. Navigation Sciences, Inc. is revolutionizing lung cancer surgery with the
cutting-edge NaviSci™ system, a real-time navigation technology designed to accurately localize and resect
lung nodules in the presence of significant tissue deformation. The key innovation is the J-bar™, an active
nodule marker with an electromagnetic (EM) sensor, placed percutaneously next to the nodule and paired with
an EM sensor on the surgical stapler to provide real-time feedback on resection margins. A clinical trial involving
25 patients validated the NaviSci System wherein the J-bar was placed in the deflated lung after nodule
palpation, and the J-bar-to-cutline (Jbar-cutline) distance was compared with pathology measurements. This
project will develop novel navigation software, EndoNaviSci, to address two critical challenges in translating the
NaviSci system to the clinic: 1) ensuring accurate nodule localization and J-bar placement without intraoperative
imaging or palpation, and 2) measuring the true margin (nodule-cutline) distance in the deflated lung despite
tissue deformation, a key prognostic factor for long-term survival. Aim 1 is to design and develop a software
navigation system, EndoNaviSci, to accurately deploy the J-bar close to the nodule in the inflated lung. Aim 2 is
to design and integrate the margin assessment algorithm with the EndoNaviSci software navigation system to
accurately estimate the nodule and margin position in the deflated lung. Aim 3 is to validate the EndoNaviSci
navigation system integrated with the J-bar in ex vivo lung and live pigs. The expected outcome of this Phase I
project is the development of the EndoNaviSci system with the J-bar to localize lung nodules using diagnostic
CT imaging and ensure complete nodule resection with sufficient margins. This project is significant since it
addresses an important problem of accurately localizing and resecting lung nodules while preserving healthy
lung function. The final milestone will be a fully integrated EndoNaviSci navigation system with the J-bar that is
ready for future human clinical trials.

Public health relevance
NARRATIVE This project will develop a novel surgical navigation system with a marking device to locate and remove small lung tumors, with safe margins, in surgical procedures that preserve healthy lung tissue and function. The marking device can be positioned before surgery and will not require the use of advanced imaging technologies during surgery. Because modern screening methods identify lung cancer at an early stage when the tumors are very small and easier to remove, this tool will benefit thousands of patients each year.